FEASIBILITY OF MEDICAL VERSUS SURGICAL MANAGEMENT OF NONVIABLE PREGNANCY

To test the hypothesis that medical evacuation of the products of conception (POC) in nonviable first trimester pregnancy by the use of methotrexate and misoprostol is effective, safe, cost-effective, and acceptable to patients. We intend to perform a randomized trial to compare the medical management of failed pregnancy to surgical removal by dilation and curettage (D&C). NCRR Clarification: research is on abnormal pregnancy/miscarriage